Opposing Roles for Microglia in the Young and Aged Neurogenic Niche

Project Summary
Neural stem cell/progenitors cells give rise to mature neurons, astrocytes and oligodendrocytes
throughout life. However, neurogenesis rapidly declines during aging and the mechanism for
age-dependent neural stem cell dysfunction is not clear. The ventricular-subventricular zone (V-
SVZ), lining the lateral ventricle, is home to the largest pool of neural stem cells in the murine
brain. We have found that microglia, the innate immune cells of the brain, are prominently
positioned throughout the young and aged V-SVZ niche. During aging, microglia undergo a
morphological and phenotypical shift from a resting state to a pro-inflammatory state.
Preliminary data suggest that secreted molecules from young microglia support proliferation and
neuronal differentiation in vitro. In contrast, microglia isolated from aged mice appear to lose
this influence on proliferation in vitro. Together, these data suggest microglia play a critical age-
dependent role in regulating neurogenesis. Although microglia are known to be important in
phagocytosis of neuroblasts, their influence on type B neural stem cells, type C transit
amplifying cells and niche cytoarchitecture is essentially unknown. Using 3-dimensional image
analysis of niche cytoarchitecture and flow activated cell sorting (FACS), we will test the
hypothesis that microglia have opposing roles in the young and aged neurogenic niche.
In aim 1, we will pharmacologically and genetically deplete microglia from the young neurogenic
niche and interrogate the impact on neurogenesis, Type B, C and neuroblast cell survival as
well as number, proliferation and position near the vascular compartment. In aim 2, we will use
heterochronic infusion of secreted molecules from young and aged microglia to directly test if
these molecules have opposing roles in neurogenesis. In aim 3, we will test if mitigating the
inflammatory phenotype of aged microglia restores neural stem/progenitor cell function. We will
also explore novel molecular candidates for microglia derived secreted molecules that support
or hinder neurogenesis. Understanding how the microglia activation state regulates
neurogenesis will have far-reaching consequences. It is widely accepted that V-SVZ neural
stem cells and their progeny contribute to brain repair. Thus, understanding how microglia
contribute to neurogenesis during tissue homeostasis and aging will not only further our basic
understanding of neurogenesis but will help in the eventual goal of using neural stem/progenitor
cells in brain therapeutics.

Public health relevance
Project Narrative Brain injury can cause permanent memory, learning and motor deficits. Adult neural stem cells divide and give rise to neurons and other support cells in the brain throughout life. These properties make neural stem cells an attractive source for brain repair. However, neural stem cell function declines during aging. This proposal aims to understand how the immune cells of the brain signal to neural stem cells during tissue homeostasis and aging. Understanding how neural stem cells are regulated will be important to identify ways we can use neural stem cells to enhance brain repair.